Pathways in Genomic Data Science (PATH-GDS)

Summary
Individuals trained in both data science and genomics are essential to fully realizing the plethora
of data at the intersection of genomics and biomedicine. Additionally, diversity in the genomics
workforce is necessary to support creativity, the study of conditions in underrepresented groups,
and ensure that research performed is generalizable and beneficial to all people. Here, we
propose the Pathways in Genomic Data Science (PATH-GDS) research experience program for
MS Statistics and MS Applied Mathematics students within the Department of Mathematical and
Statistical Sciences at the University of Colorado Denver (CU Denver). CU Denver is uniquely
positioned with two campuses: the Downtown Campus with undergraduate programs and close
proximity to diverse recruiting institutions, and the Anschutz Medical Campus with world
renowned biomedical and human genomics research. In PATH-GDS we will: (1) recruit scholars
from diverse groups underrepresented in biomedical and genomics research; (2) train
quantitative MS students from diverse backgrounds in genomics research and career skills; and
(3) create, support, and retain a diverse data science genomics community. In doing so, we will
build and support a diverse data science genomics community within Colorado, the Mountain
West, and beyond.

Public health relevance
Narrative A genomics diverse community of data scientists are needed to fully use the growing genetics and data to support biomedical research and translation into the clinic. Here, we present the Pathways in Genomic Data Science (PATH-GDS) research experience program where we will recruit, train, and build a community of genomic data scientists from groups traditionally underrepresented in biomedical research.